Implementation of streamlined, standardized blood pressure measurement protocols in primary care

PROJECT ABSTRACT
Accurate blood pressure (BP) measurements are essential for diagnosing and treating hypertension. In clinical
practice, however, BP is often not measured following a guideline-recommended protocol. This can result in
inaccurate measurements, which can lead to under- or over-treatment, and clinical uncertainty about the
patient’s BP, which can lead to therapeutic inertia (i.e., lack of treatment initiation or intensification), a major
contributor to uncontrolled BP in the US. To obtain accurate BP measurements, clinical practice guidelines
recommend a standardized series of steps, including allowing the patient to rest for >5 minutes, properly
positioning the patient, using validated equipment and an appropriate-sized cuff, and performing multiple BP
measurements with a 1–2-minute interval between readings. The guideline-recommended protocol takes
nearly 10 minutes to complete, making it difficult to implement in clinical practice. Therefore, clinics need ways
to measure BP that are both accurate and efficient to inform treatment decisions and improve BP control.
Recent studies have rigorously demonstrated it is possible to reduce the rest period from 5 to 3 or even 0
minutes and the interval between measurements from 60 to 30 seconds without compromising accuracy.
Further, for patients with BP below the threshold for hypertension, it may only be necessary to measure BP
one time. If streamlined, standardized BP measurement protocols incorporating these elements can be
implemented in primary care, this could improve hypertension treatment decisions and BP control.
The objective of this proposal is to determine whether streamlined, standardized BP measurement protocols
can be implemented in primary care. The project builds on the Alabama Cardiovascular Cooperative’s Heart
Health Improvement Project (HHIP), a quality improvement project using a practice facilitation implementation
strategy in 47 primary care practices. However, the BP measurement protocol used in the HHIP can be
optimized. In a subset of 6 HHIP practices, we will adapt the HHIP practice facilitation strategy to support
clinics to implement streamlined, standardized BP measurement protocols. We will evaluate the efficiency of
the BP measurement procedure at baseline and after 6 months of practice facilitation. We will use mixed
methods to assess factors influencing implementation of and fidelity to the streamlined, standardized protocol.
To accelerate my trajectory towards becoming an independent investigator and leader in the implementation of
evidence-based interventions to prevent and manage hypertension, I have developed a training plan with my
mentors to increase my expertise in 1) conducting research in primary care, 2) implementation science, 3)
mixed methods research, and 4) leadership skills needed to be a PI. This proposal aligns with NHLBI’s
strategic objective to optimize clinical and implementation research to improve health and reduce disease and
its December 2024 workshop on clinic BP assessment. Completing the research and training aims will position
me to submit an R01 to test whether implementing these BP measurement protocols improves BP control.

Public health relevance
PROJECT NARRATIVE The blood pressure (BP) measurement procedure recommended by US clinical practice guidelines, which includes a 5-minute rest period followed by multiple measurements performed at 1–2-minute intervals, takes nearly 10 minutes to complete, making it difficult to implement in busy primary care practices. Recent studies have rigorously demonstrated it is possible to streamline the recommended BP measurement procedure by reducing the rest period from 5 to 3 or even 0 minutes and the interval between measurements from 60 to 30 seconds without compromising BP measurement accuracy; for patients with BP below the threshold for hypertension, it may only be necessary to perform a single BP measurement. Using a practice facilitation strategy in 6 primary care practices in Alabama, this proposal will evaluate whether primary care practices can implement streamlined, standardized BP measurement protocols incorporating these elements.